Measuring and modeling gene expression trajectories: new computational-experimental approaches

RNA production, processing, and degradation are tightly regulated to articulate changes underlying a wide array
of biological processes that are central to development, function in adult tissue, and disease progression. RNA
kinetic rates jointly determine the “velocity” of each gene, which describes the rate of change in transcript
abundance. Studying RNA velocity at the single cell level allows one to access variability – either natural
heterogeneity or through pooled single cell perturbation screens – that can be used to uncover regulatory
associations by observing how velocity and kinetic rates change when the cell profile is altered. Analysis of
velocity profiles across a population of cells can in turn paint a far richer, potentially transformative picture of cell
states: in observing the dynamic profile of many single cells in a population, one can, in principle, piece together
observed short-term changes in each cell and map long-term expression trajectories that were never directly
observed, charting the paths that single cells take in dynamic processes and providing a foundation for
understanding the phenotypic space that cells can occupy. The overarching goal of work in our lab is to make
foundational advances enabling the study of single cell gene expression trajectories. To do so, we utilize an
organically interdisciplinary approach that is grounded in experimental Systems Biology and Genomics, but that
draws heavily from Machine Learning and Data Science both for computational analysis and to directly inform
experimental design. Our work is unified and distinguished by our deep commitment to integrating computation
and the principles of data science with biological experimentation in a wholistic way. The proposed research
pursues three distinct but conceptually interrelated research directions: (1) To develop new experimental
strategies that track RNA produced in single cells at multiple timepoints, allowing for more accurate estimation
of RNA velocity; the discovery of patterns of joint variation in RNA production, degradation, and expression
levels; and enabling studies that aim to learn the regulatory circuitry of RNA degradation at scale. (2) To learn
causal RNA velocity vector fields by integrating single cell RNA velocity measurements with high-throughput
genetic perturbation screens, allowing us to find a vector field map that accurately captures the trajectory
landscape and leads to new biological insight by identifying genetic programs that guide trajectories. (3) To
establish a systematic, quantitative understanding of how cell physiology impacts the “total RNA velocity” of a
cell by observing the total RNA velocity (including the 97% of cellular RNA that is ignored in mRNA studies) in
single cells under different physiological conditions, interventions to modulate a cell’s total velocity, and the
functional consequences of a total velocity limit. Collectively, these parallel and complementary research
directions focusing on single cell measurements, population-level inference, and the physiological limits of
coordinated changes in expression will establish concrete methods and conceptual frameworks that will enable
scientists tackling a wide range of fundamental problems relevant to human disease.

Public health relevance
Changes in gene expression underlie a wide array of biological processes that are central to development, function in adult tissue, and disease progression. The overarching goal of the proposed research is to develop new computational-experimental approaches for measuring and modeling gene expression trajectories. These tools will enable scientists tackling a wide range of fundamental problems relevant to human disease.